Defining the role of stress granules in cancer initiation

Project Summary.
Stress granules (SGs) – cytoplasmic aggregates formed from stalled translation initiation complexes
upon cell stress – have emerged as critical regulators of oncogenesis. SGs can confer cancer cells the ability to
withstand harsh biological conditions and can impart tumorigenic translational states through mRNA
sequestration. However, a mechanistic understanding of how SGs endogenously regulate tumorigenesis in vivo
remains elusive. My research proposal leverages a humanized zebrafish melanoma model where tumor
development can be visualized and manipulated from the precursor stage to its single cell of origin and beyond.
Using this system, I have found that SGs are formed in melanoma precursor cells and persist during tumor
initiation and progression. Furthermore, my preliminary data shows that CRISPR/Cas9-mediated ablation of a
key SG component, g3bp1, in melanoma initiating cells delays the establishment of the cancer precursor zone,
an essential initiating cell phase in the emergence of melanoma. Taken together, the overarching hypothesis
of my proposal is that SGs are formed in melanoma precursor cells to enhance viability upon tumorigenic
stress and once formed, subsequently accelerate melanomagenesis by enabling an oncogenic
translational profile. To test my hypothesis, I will first determine the impact of stress granule formation on
melanomagenesis by perturbating key components using genetically engineered zebrafish and chemical biology.
I will subsequently test whether modification of stress granule formation alters melanoma cell oncogenicity using
flow cytometry and subcutaneous transplant assays. In addition, I will elucidate the contribution of RNA
sequestration by stress granules toward melanoma development using proximity labeling and translatome
profiling. I will then functionally resolve the contribution of SG-sequestered mRNA using zebrafish genetics.
Lastly, I will perform immunostaining of human melanoma samples for proteins encoded by mRNAs with
preferential translation in melanoma initiating cells, assessing the conservation of these molecules and their
potential to serve as melanoma biomarkers. Ultimately, the results obtained herein will provide mechanistic insight
toward the functional role of stress granules during cancer initiation. As stress granules are detected across many
cancer types, this work will elucidate nodes of tumor biology that can be exploited to halt a broad spectrum of
cancers before they arise.
In this proposal, I establish training goals that will expand my conceptual and technical expertise in cancer
biology and RNA processing. In addition, I present aims that will enable the acquisition of the professional
skillsets necessary to achieve my long-term research goal, which is to run my own lab at an academic research
institution studying the basic biology of RNA processing during cancer initiation.

Public health relevance
Project Narrative. Stress granules are cytoprotective biological condensates that are induced by cell stress and are hijacked by cancer cells to withstand the harsh environment of tumorigenesis. This proposal leverages a humanized zebrafish melanoma model to test the essentiality and epitranscriptomic influence of stress granule formation in melanoma precursor cells on melanoma initiation and progression in vivo. As stress granules are observed in many cancer systems, the findings of this proposal will uncover foundational knowledge that can be used to exploit a conserved molecular pathway of cancer initiating cells, aiding the effort to control cancer in the long-term by stopping it before it can start.